Phase separation control of transcription in Ewing sarcoma

Phase separation control of transcription in Ewing sarcoma
Eighty-five percent of Ewing sarcomas are caused by translocations between the
genes EWS and FLI1, creating a powerful oncogene – EWS-FLI1. The remainder are
caused by translocations involving an EWS homologue, FUS. This sarcoma is an
aggressive primary bone tumor affecting 1 in 300,000 people annually with more than 80%
of tumors occurring in adolescents, making it the second most common pediatric bone
cancer. Half of known translocations identified in sarcomas involve one of a family of three
proteins – FUS, EWS, and TAF15, known as the FET family of proteins. Our work over
the last few years has contributed to expanding the model for FET protein regulation of
transcription. FET proteins control transcription in an organizational capacity. FET proteins
undergo an assembly process called phase separation, which is the process thought to
drive formation of non-membrane bound organelles, also called granules.
In this proposal, we highlight our accomplishments isolating an EWS-FLI1 associated
granule from cells. These granules have considerable similarity to those we have
discovered to associate with RNA polymerase II (RNA Pol II) during transcription, which
we refer to as transcription granules. This proposal aims to establish a model that EWS-
FLI1 fusion protein seed aberrant granules that incorporate EWSR1 and other FET
proteins to alter transcription and promote tumorigenesis. Our proposed work will
investigate basic molecular mechanisms by which EWS-FLI1 can contribute and drive
pediatric sarcoma pathology. Our proposal involves three aims. (1) We will determine the
binding partners that comprise fusion protein granules for EWS-FLI1. (2) We will
investigate EWS-FLI1 and EWSR1 activities to bind nucleic acids, phase separate, and
alter transcription through effects on nucleic structures. Finally, (3) we will investigate how
changes to DNA structure and chromatin are linked to aberrant phase separation by EWS-
FLI1, EWSR1, and additional remodeling factors.

Public health relevance
This project seeks to understand the role of EWSR1 to participate in the activity of a fusion protein, EWS-FLI1, and drive Ewing sarcoma development by involving a process known as phase separation, creating a semi-stable molecular scaffold. Our working model is that these molecular scaffolds localize the machinery for transcription to active genes and aberrant molecular scaffolds introduced by the EWS-FLI1 fusion can titrate away EWSR1 activity. This proposal uses a proteomics, genomics, and biochemical approaches to investigate the ability of EWS-FLI1 to redirect EWSR1 activity in the cell.